Michigan Institute for Clinical and Health Research (MICHR)

Project Summary The purpose of the proposed supplement is to support MICHR’s ability to contribute data to the National COVID Cohort Collaborative (N3C) initiative. This National Center for Advancing Translational Science supported initiative is requesting a complete dataset containing electronic health records (EHR) of COVID-19 positive and tested cases. This dataset will be a separate CDM from the overall CDM, that will need to be separately maintained, refreshed more frequently, expanded with new data components, and have institutional policies revised to accommodate the innovative vision of how such data can be securely shared, combined with other institutions’ data, and analyzed in a manner consistent with patient privacy. The curation and governance of this unique instance of the UM EHR will require additional effort from both MICHR staff as well as staff outside of MICHR including the Health Information Technology & Services (HITS) team, the Office of Research, the Data Office for Clinical and Translational Research (DOCTR), the institutional review board (IRB), and the Office of Compliance. MICHR will take the lessons learned from tackling the unique regulatory, compliance, and governance challenges that arise from this project to create best practices related to lowering the barriers of future projects. The N3C platform is likely to serve as a model for how future responses to national crises can be accomplished.

Public health relevance
Project Narrative As the COVID-19 pandemic continues to spread across the globe, researchers and academic institutions are racing to find treatments as well as develop vaccines to prevent infection and reduce the devastating effects of the coronavirus. By harmonizing COVID-19 electronic health record data from the University of Michigan as well as other CTSA hubs into a centralized data resource that the research community can leverage to study COVID-19, the N3C is providing an opportunity to contribute to the national response to this pandemic.